A Tissue-Specific Soluble Platelet-Derived Growth Factor Receptor-beta Isoform Retains Functional Capacity

PROJECT SUMMARY / ABSTRACT
Microvascular dysfunction underlies a wide range of devastating diseases, from Alzheimer’s Disease to cancer.
However, mechanisms underlying vessel maintenance that become dysregulated in vascular-related pathologies
are still emerging, fueling the advancement of blood-based diagnostics and bioengineered therapeutics. We
recently identified a truncated, alternative splice variant of Platelet-Derived Growth Factor Receptor-β (PDGFRβ)
that encodes a soluble PDGFRβ isoform (sPDGFRβ), which may harbor potential as a future diagnostic and
therapeutic target. Receptor tyrosine kinases (RTKs), like PDGFRβ, often have soluble counterparts that are
generated via alternative splicing to function as “decoy” receptors to negatively regulate ligand-induced signaling
of the full-length receptor. Full-length PDGFRβ is expressed by pericytes (PCs) to mediate their recruitment to
microvascular endothelial cells (ECs) producing the cognate ligand Platelet-Derived Growth Factor BB (PDGF-
BB) – where PCs promote vessel stability and tune permeability. However, microvascular PC density and vessel
permeability vary between tissues and specialized vascular beds, with vessel dysfunction often associated with
PC loss and misregulated PDGFRβ--PDGF-BB signaling. Thus PDGFRβ-mediated PC recruitment is vital to
vessel integrity, although the exact mechanisms that govern it remain unclear. Recent studies report a large
sPDGFRβ produced via proteolytic cleavage in cerebral pathology scenarios. However, our data indicate that a
small sPDGFRβ is generated via alternative splicing in a broad range of normal, healthy tissues, though it is also
likely involved in disease states. We recently elucidated the full mRNA sequence of sPdgfrb, enabling targeted
manipulation and analysis approaches. In addition to broad and differential expression across various tissues,
our preliminary findings indicate overlap with full-length Pdgfrb (fPdgfrb)-expressing cells in mouse brain, and
presence of immunolabled, non-vessel associated sPDGFRβ protein signal in the brain parenchyma. These
findings, considered alongside established mechanisms of ligand sequestration in related RTKs, inform our
hypothesis that PDGF-BB bioavailability is regulated by alternatively spliced sPDGFRβ to mediate PC-vessel
recruitment and tune vessel permeability. Therefore, using complementary in vitro and in vivo models, we
propose investigation of sPDGFRβ potential to bind and regulate (i) PDGF-BB bioavailability, (ii) activation of
full-length PDGFRβ (fPDGFRβ), (iii) PC dynamics, and (iv) developing vessel morphology and permeability. We
will investigate sPDGFRβ cell-specificity, and spatio-temporal distribution in various tissues to determine the
extent of its functional role. In addition, we will assess the potential of sPDGFRβ as a biomarker and treatment
in vascular-related pathologies involving PC loss. This work will advance our understanding of mechanisms
underlying vessel maintenance and integrity, and lay the groundwork for follow-on collaborative studies aiming
to develop sPDGFRβ as a potential diagnostic tool and therapeutic target in cardiovascular diseases.

Public health relevance
PROJECT NARRATIVE This study aims to establish the physiological role of a previously unreported soluble Platelet-Derived Growth Factor Receptor-β (sPDGFRβ) that appears to be broadly expressed in healthy tissues. Similar to related soluble growth factor receptors, sPDGFRβ may regulate the bioavailability of a key growth factor that contributes to microvascular stability, with aberrant sPDGFRβ expression associated with vessel dysfunction. The purpose of this study is to advance our understanding of how and where sPDGFRβ may regulate vessel function, with the long-term goal of exploring how sPDGFRβ may be developed as a diagnostic tool and/or a target for bioengineered therapies.